Administrative Core

Abstract/Summary The administrative core of this translational program is integral to the Horae Gene Therapy Center (GTC) of UMMS, and provides the mechanism for pre- and post-award administration of the program, for convening of the investigators who constitute the key personnel of the subprojects and cores, and for assembling the External Advisory Committee to provide ongoing peer review and input to all programmatic initiatives. The administrative core interacts at all levels with the central administration of UMMS (including the office of the Provost/Dean, the Office of Research, and the Center for Clinical and Translational Science). Finally, the Administrative core will provide assistance to the communication of results through peer review publications and presentations at national meetings relevant to pulmonary disease, gene therapy, and alpha-1 antitrypsin deficiency, specifically.